DP21-001 Minnesota Pregnancy Risk Assessment Monitoring System, Component A

Project Summary:
The Minnesota Pregnancy Risk Assessment Monitoring System (PRAMS) is an ongoing,
population-based surveillance system designed to identify and monitor selected maternal
experiences and behaviors that occur before and during pregnancy and during the child’s early
infancy among a stratified sample of women delivering a live birth. The purpose of PRAMS is to
collect state-specific, population-based data on maternal and child health indicators of high
scientific quality to inform programs and policies relating to maternal and infant health. PRAMS
began as part of Centers for Disease Control and Prevention (CDC) initiative to reduce infant
mortality and low birth weight. The objectives for PRAMS are: 1) to continue surveillance of
selected maternal attitudes, behaviors and experiences that occur prior to, during, and after
pregnancy; 2) provide a high quality data source for ongoing monitoring of risk factors for
maternal and infant health; 3) to analyze and translate PRAMS data to inform planning and
evaluation of public health programs and policy; 4) to build capacity for collecting, analyzing
and translating data to address relevant maternal and infant health issues. Minnesota-specific
objectives include addressing the large disparities in pregnancy-related health that are masked
by the small size of Minnesota’s populations of color and American Indians and to provide
useful results to inform and influence public health planners throughout the state. Minnesota
PRAMS contributes to the mission of the Minnesota Department of Health (MDH) “protecting,
maintaining and improving the health of all Minnesotans” by contributing to key MDH goals,
most importantly, that all Minnesotans are given a healthy start in life. Minnesota PRAMS
collects information from Minnesota-resident mothers who had a live birth in Minnesota within
the last three to six months. Mothers are selected using a monthly stratified, systematic sample
of recently filed birth certificates. Currently, U.S.-born African American and American Indian
women are oversampled as these are priority higher-risk populations. Mothers are offered the
survey by mail and later by telephone. The monthly samples are combined into an annual file,
weighted for non-response, non-coverage and sample design. Results from MN PRAMS are
used to provide weighted annual estimates of experiences and behaviors of Minnesota-resident
women who had a live birth in Minnesota that year.

Public health relevance
Project Narrative: Minnesota PRAMS is relevant to public health because the results approximate the number of women in the state who had certain health behaviors or experiences related to pregnancy, as well as identifies subgroups at higher risk (U.S.-born African American and American Indian). State programs use these results to evaluate the success of existing activities, laws and policies serving pregnant women and infants and to develop programs to address emerging areas of need. Finally, researchers use PRAMS results to explore the relationships between specific behaviors and experiences and how the health of women and infants is affected.